Outreach Core

ABSTRACT
The Outreach Core is based on the premise that the US-Mexico border and Indian Country in the
northwestern regions of New Mexico (NM), as well as the Central region of Washington State (WA) are largely
rural and medically underserved areas where inequities are severe, especially among Hispanic/Latinx,
American Indian (AI), and LGBTQAI+ populations. These geographical areas are the foci of the Outreach
Core’s work. Long term, the Partnership aspires to increase the health equity in these regions. To do so, the
Specific Aims are: 1) To integrate community engagement activities and practices within the Partnership for
Advancing Cancer Research (PACR); 2) To increase capacity for community-academic partnerships to
successfully use community-based participatory research (CBPR); and 3) To build on and use evidence-based
programs (EBPs) to promote cancer equity in Latinx, AI, and LGBTQIA+ populations. The Outreach Core was
very successful in the U54-III, reaching 4,631 individuals in NM and 3,287 in WA. Since the outbreak of the
COVID-19 pandemic, in-person cancer prevention education and other Outreach Core activities were adapted
to online platforms in English and Spanish. At the request of the Community Action Boards (CABs), information
on COVID-19 and vaccination was disseminated through social media with positive results. For this U54-IV, we
will follow the Partnership Guiding Principles of 1) restructuring scientific environments; 2) restructuring scientific
processes; and 3) restructuring scientific engagement, and will work collaboratively with our CABs to foster mutual
understanding of the Partnership and the community organizations represented by the CABs to ensure that NMSU
and Fred Hutch equitably engage communities in all the activities. CAB discussions about the various Research
Projects and Cores will be initiated as well as bi-directional discussions on community-based participatory
research (CBPR). The Partnership will also endeavor to establish community organization expertise in research
initiatives by providing training and education in research. The expected end result will be community-oriented
Pilot and Pre-Pilot projects funded by the Partnership. Five modules fostering inclusion of community members in
research practices will provide opportunities for historically marginalized communities to voice their strengths and
ways of knowing through collaborative experiences. Finally, the Outreach Core will continue to collaborate with the
CABs and communities on evidence-based programs such as Screen-to-Save (a colorectal cancer screening
program), Yéego (a Navajo healthy eating project), e-Learning by the Cooperative Extension Services (on healthy
lifestyle behaviors), and Cancer 101 (a series on cancer causes, prevention and detection). The Planning &
Evaluation Core (P&E Core) will evaluate the formative and summative outcomes of the activities.